PHASE II STUDY SAFETY/EFFICACY MULTIPLE DOSAGE RECOMBINANT ERYTHROPOIETIN IN RA

Recombinant human erythropoietin was given in two phases to 17 patients with rheumatoid arthritis and anemia. No adverse reactions were seen and with these visits.